Admin Core

Administrative Core Summary
The Mobile Toolbox 2 (MTB2) Administrative (Admin) Core will provide overall administrative and
organizational oversight and management to ensure the effective and efficient support of the Mobile Toolbox
platform (MTB) and associated studies (Aim 1). This will include supporting the financial, organizational,
communication, and logistical needs of all the MTB constituents, external entities, and all other Cores.
Specifically, the Admin Core will enable communication and collaboration across MTB2 including the Steering
Committee, NIH, External Scientific Panel, early adopters, and all other external networks (Aim 2). The Admin
Core will establish and implement administrative, statistical, and technical support structures to enable measure
development and modification as needed and ensure the efficient collection, analysis, and storage of data. The
Admin Core will also develop and implement a management plan. Management activities will include organizing
and managing resources in a manner that advances MTB objectives, monitoring and documenting progress
toward reaching those objectives, and helping to identify and resolve problems as needed. The Admin Core will
also enable efficient and regular communication and collaboration amongst and between MTB constituents and
external entities through multiple mediums, including regularly scheduled meetings. The core will provide
logistical support for meetings, document and help implement decisions and policies approved by MTB
governance, and help ensure that relevant information and documentation is easily accessible to the scientific
community.